Developmental Funds

PROJECT SUMMARY (See instructions): CCSG Developmental Funds are critical to the success of Dana-Farber/Harvard Cancer Center. The Center carefully invests these funds to stimulate investigation, member engagement, and inter-programmatic collaboration in high priority areas. It is an important sign to the members that the Center will invest in them and in areas of scientific importance. Developmental Funds are especially important to DF/HCC due to the lack of sources for discretionary funds that other centers may enjoy from university, state, or patient donor funds. At the time of the last renewal in 2005, Developmental Funds was rated outstanding.